Core A: Administrative Core

CORE SUMMARY
The Administrative Core (Core A) is directed by Roy Herbst, Principal Investigator of the Yale SPORE in Lung
Cancer (YSILC), and co-directed by Ed Kaftan, with support from the program financial management team.
Careful oversight by the Administrative Core will be critical to ensure the success of the Yale SPORE in Lung
Cancer. Core A is an extension of existing infrastructure provided by YCC Research Administration to support
and facilitate transdisciplinary research efforts. The Administrative Core serves as the central coordination
point for all YSILC investigators, with responsibility for monitoring the progress of all projects and cores toward
a translational/clinical endpoint. The Core Director and Co-Director along with the YISLC Co-PI (Dr. Chen)
have responsibility for leading the YSILC program, setting translational research priorities, identifying new
translational research opportunities from emerging data, monitoring the progress of all projects, cores and
developmental projects and determining changes in direction of projects, cores and translational research as
needed. Interactions among YSILC investigators is facilitated by Core A to accelerate the translation of
laboratory findings into the proposed and future clinical studies. If required, the Core A Director will manage
conflicts among YSILC investigators. As a team, the Core personnel monitors finances, maintains
communications among project and core leaders and coordinates meetings, including the weekly lung cancer
translational group seminar series, monthly meetings of the Executive Committee, annual meetings of the
Internal/External Advisory boards and the annual YSILC SEP and DRP Symposium. In addition to these
functions, the Core is the primary interface with the NCI, other lung cancer SPOREs, Yale Cancer Center and
Yale University, and coordinates outreach efforts, including publications (internal and external), website
development, seminars, patient/research advocacy activities, and fundraising programs. Through these
administrative activities, Core A is essential to the organization of the YSILC program, to developing a
widespread culture of lung cancer basic/clinical/translational research at Yale and to the efficient achievement
of the stated program objectives, with the ultimate goal of a significant clinical impact for patients with lung
cancer.

Public health relevance
PROJECT NARRATIVE The Administration Core (Core A) is essential for leading the Yale SPORE in Lung Cancer (YSILC). The Core provides scientific, financial and administrative oversight for all YSILC activities and make critical decisions regarding project oversight and management.